CCSG Supplement: ATR Inhibition in Advanced PD(L)1-Refractory Merkel Cell Carcinoma

EDDOP Leadership Award-P30 Administrative Supplement: The MATRiX Study
Title: A Phase 2 Study of ATR Inhibition in Advanced PD-(L)1-Refractory Merkel Cell Carcinoma
Abstract (30 lines of text)
The success of checkpoint blockade immunotherapy for patients with advanced Merkel cell
carcinoma (MCC) has transformed the management of this cancer. Specifically, trials of anti-PD-
(L)1 agents led by our Seattle-based translational team resulted in three FDA approvals
(avelumab, pembrolizumab, and retifanlimab). Nearly 50% of MCC patients achieve durable
disease control with immune checkpoint inhibitors, however, novel salvage treatment options are
required to address the unmet clinical need for patients with primary and acquired resistance.
Aggressive solid tumors that rapidly multiply, such as MCC, are under increased replication stress
(as evidenced by high Ki-67 positivity). This happens in part through loss of early cell cycle
checkpoints, biologically characterized by dysregulation of Rb and p53 signaling paired with Myc
upregulation. Dividing cells rely on ATR (ataxia telangiectasia and Rad3-related protein) kinase
that acts as a ‘quality control’ mechanism to ensure completion of DNA replication prior to the
beginning of mitosis, failure of which results in cell death. After more than a decade of effort,
multiple potent and specific ATR inhibitors (ATRi) are now available and being explored in
relevant preclinical and clinical settings.
Excitingly, early preclinical experiments performed by several labs in addition to our preliminary
data suggest that ATRi alone or in combination with low-dose radiation induces canonical markers
of immunogenic cell death. MCC tumor cells treated with an ATRi (with or without radiation)
demonstrate increased innate immune activation as evidenced by expression of calreticulin and
MHC-I on the cell surface as well as type I interferon production. In addition, antigen presenting
cells (APCs) become activated following exposure to ATRi-treated tumor cells. APCs upregulate
MHC-I, CD80 (B7-1) and CD86 (B7-2) expression in this setting augmenting both signals 1 and
2 required for T-cell activation. This suggests that tumors could thus become an in situ vaccine.
Importantly, the ability of ATRi to promote MHC-I expression and induce antigen presentation
machinery may help overcome immune evasion associated with PD-1 resistance in MCC patients.
Excitingly, these studies have led to the recent approval of LOI #10592, an NCI-sponsored
multicenter Phase II trial that will explore an ATR inhibitor in patients with MCC resistant to PD-1
pathway blockade. The trial will be randomized to investigate the capacity of ATRi +/- anti-PD-L1
agents for potentiation of anti-tumor immunity in refractory tumors. Detailed characterization of
biological correlates of response will help evaluate the immunostimulatory mechanisms
underlying ATR inhibition in MCC and other biologically analogous cancers.

Public health relevance
EDDOP Leadership Award-P30 Administrative Supplement: The MATRiX Study Title: A Phase 2 Study of ATR Inhibition in Advanced PD-(L)1-Refractory Merkel Cell Carcinoma Narrative (no more than 3 sentences) With limited therapeutic indications for the nearly half of patients with PD-1 refractory Merkel cell carcinoma (MCC), ATR inhibition will be explored for its immunogenic potential in this advanced disease setting. Given its high replication stress, inherent immunogenicity, and sensitivity to DNA damage, MCC is a nearly ideal cancer in which to test whether an ATR inhibitor could help stimulate an anti-tumor immune response. Characterization of immune correlates of clinical benefit will be performed through our NCI-approved multicenter Phase II study.